Pathophysiology of Active and Latent Myofascial Trigger Points

PROJECT SUMMARY
Pain deriving from a range of health concerns including headache, low back pain, osteoarthritis, carpal tunnel
syndrome, as well as post-surgical and cancer pain have been linked to myofascial trigger points (TrPs). The
TrP is a tender nodule along a taut band of muscle. Two states of the TrP are known to exist: active and latent.
In the active state, the TrP is spontaneously painful and elicits pain referral mimicking the clinical complaint.
The latent TrP is not spontaneously painful and any referred pain it elicits upon palpation is not related to a
clinical pain complaint; the latent TrP is thought to be an intermediary state between healthy and an active TrP.
Evidence from ultrasound indicates latent TrPs exhibit reduced blood flow, which is further reduced in active
TrPs, suggestive of metabolic disruption and cellular stress. In line with that observation, hypothesized TrP
models predict reduced glucose and elevated lactate in TrPs, however a pilot massage intervention trial that
reduced active TrP pain found no change in glucose and an increase in lactate. The discrepancy between the
TrP model and empirical evidence argues that cellular metabolism within a TrP may behave differently than the
well-accepted model predicts. Lactate has also been linked to nociceptor sensitization, which could explain
differences in local or referred pain experience. Furthermore, the differences in blood flow between latent and
active TrPs could result in metabolic differences that may be informative as to the formation, progression, and
perpetuation of TrPs.
The present study will use a targeted and non-targeted metabolomics approach to understand the metabolic
environment within both types of trigger points and healthy muscle. Latent TrPs from healthy individuals and
active TrPs from individuals with tension-type headache will be investigated. The targeted approach will focus
on glucose and lactate to determine whether carbohydrate energy balance is different within healthy muscle
and trigger point sites. The non-targeted approach will screen for thousands of metabolic biomarkers within
healthy muscle and the TrPs to identify relative differences in metabolites that could identify which metabolites
lead to development of a latent TrP, progression to an active TrP, or perpetuation of the active TrP.
The experiments described in this proposal will provide insight into the internal environment of TrPs. Should
this exploratory study reveal disruption to carbohydrate energy balance or identify differences in biomarkers
within latent or active TrPs a mechanism for the formation or progression of the TrP will become clear. This
information could be used to optimize intervention techniques that will reverse or prevent muscle-derived pain.
This proposed study will address the key goal to “Develop and validate biomarkers for chronic pain or other
key symptoms to be used in studies of mind and body approaches” from the Funding Opportunity
Announcement PA-18-322.

Public health relevance
PROJECT NARRATIVE Myofascial trigger points (TrPs) are common contributors to pain conditions ranging from myofascial pain syndrome, headache, low back pain and even to osteoarthritis and cancer pain. Our understanding of the metabolic physiology within a TrP is important for understanding how TrPs develop and subsequently how to optimize effective treatment strategies.